A Novel Pharmacotherapy for Alcoholism: Evaluation of Reward, Aversion, Compulsivity, Withdrawal & Reinstatement

Project Summary
Alcohol use disorders (AUD) place an enormous burden on our society. In addition to their
psychological and social toll, it is estimated that AUDs cost the US economy $249 billion in the year
2010 alone. Although there are already several effective behavioral and pharmacological treatments,
there is an urgent need for new pharmacotherapies that act via novel mechanisms.
We have recently shown that inhibitors of the enzyme Glyoxalase 1 (GLO1) reduce voluntary
ethanol drinking in mice (McMurray, et al 2017a). GLO1 is a cytosolic enzyme that metabolizes
methylglyoxal (MG). MG is a non-enzymatic side product of glycolysis and is therefore present in all
cells. Thus, GLO1 activity is inversely related to MG concentration. We have previously shown that
transgenic overexpression of GLO1 increases anxiety-like behavior in mice and decreases MG
concentrations in the brain. Reciprocally, we showed that direct administration of MG, genetic
knockdown of Glo1 or inhibition of GLO1 using a small molecule inhibitor all decrease anxiety-like
behavior and increase MG concentrations in brain. We found that even higher doses of MG produced
locomotor depression, ataxia and hypothermia; taken together these data suggested that MG might
be acting through GABA-A receptors. Indeed, using a patch clamp procedure, we found that MG is a
competitive partial agonist at GABA-A receptors. We also showed that MG is highly selective: it does
not activate GABA-B receptors, other ligand gated ion channels or voltage gated ion channels. More
recently, we have shown that GLO1 inhibition has antidepressant-like effects, suggesting that GLO1
inhibitors might treat anxiety and depression, both of which are comorbid with AUD. Given the
importance of GABA-A signaling in the effects of ethanol, we speculated that GLO1 and MG might
also modulate ethanol-related behaviors, which led us to study the effects of GLO1 on ethanol
drinking. Those studies showed that inhibition of GLO1 decreased ethanol drinking, which is the
rationale for the experiments proposed in this application.
We are proposing studies aimed at understanding why inhibition of GLO1 reduces voluntary
ethanol drinking. In Aim 1 we will use the intracranial self-stimulation (ICSS) procedure to examine
the acute and chronic effects of genetic and pharmacological manipulations of GLO1 on hedonic and
anhedonic responses to ethanol in mice. In Aim 2 we will use conditioned place preference (CPP)
and conditioned taste aversion (CTA) to study the effects of GLO1 on preference and aversion for
ethanol in mice. Finally, in Aim 3, we will use the chronic intermittent ethanol (CIE) procedure to
examine the effects of Glo1 inhibitors on acute ethanol withdrawal, compulsive-like responding for
ethanol and reinstatement of ethanol seeking behavior after protracted abstinence in rats.

Public health relevance
PROJECT NARRATIVE In this proposal we are studying how and why inhibitors of the enzyme GLO1 decrease ethanol drinking in mice. We are also examining models of compulsive-like ethanol self-administration in rats that are dependent on ethanol. These studies are important for our attempts to develop GLO1 inhibitors for use as a therapy for alcohol use disorder and also will give us fundamental insights into how GLO1 is related to alcoholism.